Online and offline multiverse spillover: Mapping the ecology of youth mental health

Abstract
Rates of mental and behavioral health disorders are increasing among adolescents coinciding with in-
creases in overall time spent engaging with social media and other online activities. This trend has led to
a strong media narrative that online engagement is spilling over into offline mental and behavioral health.
However, empirical evidence is relatively weak and mixed between positive, negative, and null effects.
Some evidence suggests there may be benefits from online engagement. For instance, youth who iden-
tify as sexual and/or gender minorities (SGM) may benefit from receiving emotional support in desig-
nated online spaces that support SGM identities. Other research finds negative impacts for girls’ mental
health related to online engagement as well as increased exposure to cyberbullying among SGM youth.
There is a strong potential of high impact interventions that consider adolescents embedded within the
online context but this area of research is limited by cross-sectional, self-report methods and an almost
exclusive focus on time spent online and unidirectional associations rather than bidirectional within-per-
son mechanistic processes and rich assessments of online engagement. Passive assessment of online
engagement and mental health indicators can provide ecologically valid data on naturalistic adolescent
online behaviors and experiences, recognizing that adolescents both shape and are shaped by their
online environments. Informed by the Compensatory Internet Use Theory (CIUT), this study leverages
multiple data streams (e.g., survey data, ecological momentary assessment (EMA), passive digital trace
data from smartphones) to test mechanistic within-person processes that underlie bidirectional links be-
tween offline mental and behavioral health and online behaviors and experiences, identifying potentially
modifiable targets for future prevention and intervention development. We will recruit both a clinical and
non-clinical sample of adolescents age 13-15 (n=450) with an overrepresentation of SGM youth to partic-
ipate in the following research activities: (a) three bursts of a 21-day EMA of moods and motivations for
engaging online; (b) three pre-burst and three post-burst surveys of mental and behavioral health and
online experiences; and (c) passive assessment of digital trace data related to online behavior (e.g., so-
cial networking, messaging, music, typed language) and proximal indicators of mental health (e.g., sleep,
activity). To address study aims, natural language processing will be utilized to detect hidden mental
states in language data and dynamic structural equations modeling will be used to estimate between-
person differences in within-person adaptive and maladaptive mechanistic pathways leveraging all data
streams. These results are a necessary next step in understanding how real world, ecologically valid as-
sessments of online engagement longitudinally and acutely impact mental health and wellbeing as well
as identifying modifiable targets to promote youth mental health and well-being in the digital age.

Public health relevance
The proposed research is relevant to public health because it utilizes fully integrated survey methods, ecological momentary assessment, and passive assessments from smartphones to test the within-per- son bidirectional mechanisms that underlie online experiences and offline risk, resilience, and mental health among a clinical and non-clinical sample of adolescents as well as disparities by sex and for sex- ual and gender minority youth. This is a necessary next step to understanding the digital ecology of youth development and identifying potentially modifiable targets for interventions to prevent poor mental and behavioral health and promote resilience in the digital age. Thus, the proposed research is aligned with NIMH’s mission to transform the understanding and treatment of mental illnesses though basic and clini- cal research, paving the way for prevention, recovery, and cure.